Synthesis and Modification of Natural Products through Inert Bond Cleavage Reactions

Project Summary
Medicinal chemists have consistently sought inspiration from natural products and their
synthetic derivatives when exploring potential therapeutic lead compounds. These compounds
frequently exhibit polycyclic architectures with numerous Csp3 stereocenters, contributing to
heightened molecular rigidity. Additionally, clinical candidates which contain many stereocenters,
topologically rich molecules, have been shown to exhibit less off-target effects. However, many
synthetic methods solely modify the periphery of a molecule, which results in negligible three-
dimensional change to the core scaffold. This proposal aims to develop protocols to alter the
molecular topology of biologically active molecules; therefore, providing access to untapped
chemical space and novel approaches to potentially improve a clinical candidate’s biological
properties (Project 1). This project centers around developing several photochemical
deconstructive epimerization protocols, involving an initial C–C bond cleavage, formation of a
radical intermediate, and C–C bond reformation with the altered stereochemistry. This new mode
of precision molecular editing may enable the opportunity to rapidly modify existing natural
product and therapeutic libraries as well as the ability to synthesize compounds that would
previously be challenging to access without lengthy de novo syntheses. Nevertheless, certain
secondary metabolites are isolated from natural sources in minute quantities, which may limit the
potential for direct modifications to a core scaffold. To overcome this hurdle, we also seek to
develop new convergent retrosynthetic strategies that allow for the rapid and scalable total
syntheses of natural products (Project 2). Our second proposal aims to utilize common, stable,
and widely available precursors, such as alcohols and amines, for the direct execution of
convergent fragment coupling reactions. By in situ cleavage of these inert C–C and C–heteroatom
bonds, a radical intermediate is formed which we harness in various coupling reactions. We will
further employ these protocols in the synthesis of several biologically active terpenoids.

Public health relevance
Project Narrative Natural product structures have played a significant role in shaping the landscape of approved therapeutics and clinical candidates for the treatment of numerous human ailments, including cancer, microbial infections, malaria, and HIV. As such, methods to rapidly synthesize and predictively modify these complex molecules, which contain diverse architectures and functional group arrangements, are necessary. This proposal aims to develop protocols to cleave inert bonds present in both abundant precursors as well as complex natural products, thereby enabling strategies for the stereochemical manipulation of highly substituted carbon centers and new convergent coupling protocols utilizing ubiquitous functional handles (e.g., amines and alcohols).